Heat therapy to improve functional performance in Heart Failure with Preserved Ejection Fraction

PROJECT SUMMARY
Heart failure with preserved ejection fraction (HFpEF) is a debilitating disease with high morbidity, mortality and
health care expenditures. Impaired physical capacity is the primary symptom and a strong determinant of
prognosis and reduced quality of life (QoL). The prevalence of HFpEF is higher in women and increases with
age. Women with HFpEF present with worse exercise intolerance, microvascular dysfunction, and QoL relative
to men. However, older women remain consistently underrepresented in clinical trials. The specific problem is
that very few therapies currently exist to improve functional performance and QoL in patients with HFpEF. For
these reasons, HFpEF is recognized as the single greatest unmet need in cardiovascular medicine today. The
objective of this proposal is to determine, for the first time, the benefits of home-based leg heat therapy (HT) on
exercise tolerance and QoL in older women with HFpEF. This novel approach consists of custom engineered
trousers, instrumented with a network of small flexible tubes connected to a portable water pump. Hot water is
circulated through the tubes, evenly heating the buttocks, thighs and calves. The system is convenient for
application in the home setting without supervision. These customized trousers were demonstrated to be safe,
well-tolerated and to enhance exercise tolerance in elderly individuals with restricted mobility. In a preclinical
model of HFpEF, we recently found that repeated HT enhanced skeletal muscle mass, microvascular function
and treadmill running performance. Building upon our preliminary data, we propose to conduct a randomized,
double-blind, sham-controlled clinical trial in 34 older women (≥60 years of age) with HFpEF to establish the
effect of daily, home-based leg HT for 8 weeks on functional capacity and QoL. Patients randomized to the leg
HT group (n=17) will be asked to apply the treatment daily for 90 min using water-circulating trousers perfused
with water heated at 42°C. In the sham group (n=17), water at 33°C will be circulated through the trousers. The
primary outcome is the change in exercise capacity during treadmill tests between baseline and the 8-week
follow-up. Secondary outcomes include changes in perceived QoL and cardiovascular responses to exercise. In
Aim#2, we will determine the tissue-level mechanisms by which HT affects muscle strength and exercise
performance. We will assess skeletal muscle morphology (magnetic resonance imaging), leg strength (isokinetic
dynamometry), microvascular oxygenation and blood flow (near-infrared spectroscopy, Fick equation), and
mitochondrial respiration (31P-magnetic resonance spectroscopy). If the conclusions based on our preliminary
data are substantiated, the proposed experiments will provide an evidence-based framework of feasibility and
efficacy of a novel, straightforward approach to improve functional performance and QoL in patients with HFpEF.
Given its accessibility, tolerability and ease of use, HT has the potential for rapid translation and application in
the clinical setting, thereby opening new horizons for the non-invasive management of HFpEF.

Public health relevance
PROJECT NARRATIVE Heart failure with preserved ejection fraction (HFpEF) affects disproportionately older women, but very few effective treatments are currently available. The goal of this proposal is to evaluate the benefits of home-based heat therapy (HT) on physical capacity and quality of life in older women with HFpEF. Since this intervention is non-invasive, non-pharmacological and widely accessible, there is high potential for this work to rapidly translate into clinical practice and result in significant improvements in patients’ lives.